FY23 FACILITIES TO C-WESTLAKE REFURBISHMENT

Building 560 is a 183,548 sq. ft. masonry and steel structure constructed in
1956. This project will refurbish Wing 2, Floor 2 of Building 560,
specifically Room Nos. 22-31, 22-56 and 22-62 – 22-65, to create upgraded
laboratories, a hot room, a microscope room and a tissue culture lab.